DP21-001 PRAMS COMMONWEALTH HEALTHCARE CORPORATION

Component A: Core Surveillance
5-year period of performance
The Commonwealth of the Northern Mariana Islands Pregnancy Risk Assessment
Monitoring System (CNMI PRAMS)
ABSTRACT
Commonwealth of the Northern Mariana Islands Pregnancy Risk Assessment Monitoring
System (CNMI PRAMS) will be a joint research project between the Commonwealth Healthcare
Corporation (CHCC) and the Centers for Disease Control and Prevention (CDC). The project
involves the development and completion of a protocol and implementation of a population-
based surveillance system designed to identify maternal attitudes and experiences before,
during and after pregnancy. Research indicates that maternal behaviors during pregnancy
impact infant birthweight, gestation and mortality rates. The CNMI PRAMS will strengthen
capacity in the CNMI to produce high quality data not available from other sources relating to
pregnancy and the first few months after birth and enable the monitoring of maternal and infant
health indicators over time. The goal of CNMI PRAMS is to identify maternal risk behaviors that
may affect both maternal and infant health. Findings from CNMI PRAMS will be used to
enhance the understanding of maternal behaviors among the territory’s diverse population and
their relationship with adverse pregnancy outcomes. The CNMI CHCC will use PRAMS
surveillance data for program planning and evaluation and influencing public health practice and
policy for maternal and child health programs.
Commonwealth of the Northern Mariana Islands
Pregnancy Risk Assessment Monitoring System (CNMI PRAMS)
RFA-DP-21-001

Public health relevance
Component A: Core Surveillance 5-year period of performance The Commonwealth of the Northern Mariana Islands Pregnancy Risk Assessment Monitoring System (CNMI PRAMS) PROJECT NARRATIVE The Commonwealth of the Northern Mariana Islands Pregnancy Risk Assessment System (CNMI PRAMS) is a surveillance project of the Centers for Disease Control and Prevention (CDC) and the Commonwealth Healthcare Corporation. The project collects information about maternal attitudes and experiences before, during, and after pregnancy. The data that will be available through the CNMI PRAMS is not available in any other data source and the results will be used to inform programs and policies aimed at reducing health problems among mothers and babies in the CNMI. Commonwealth of the Northern Mariana Islands Pregnancy Risk Assessment Monitoring System (CNMI PRAMS) RFA-DP-21-001